Single-Cell Epigenomics, Transcriptomics, and Bioinformatics Core

SUMMARY
The PCEN at UVA will support a combined biomedical research core to assist investigators in two important
areas: 1) Transcriptome and epigenome technologies and 2) Bioinformatics. The Single Cell Epigenomics,
Transcriptomics, and Bioinformatics core will be directed by experienced researchers (Silvia Medrano, Ph.D.
and Nathan Sheffield, Ph.D.) and staffed with highly trained personnel. Through the Single Cell Epigenomics
and Transcriptomics component of the core, the PCEN will generate new data that will require substantial single
cell and bioinformatics resources and expertise. The Bioinformatics component of the core will work closely with
the single cell component and provide both computational infrastructure and analytical support to ensure that
the investigators convert this important data into knowledge. By integrating all these services within a single
core, we will ensure that PCEN investigators carry out their research in a coordinated, cost-effective, and efficient
manner. The core will serve as a resource for the two PCEN main Research Projects and Pilot Projects at all
times. Furthermore, the core will support the broader pediatric kidney research community at UVA and other
institutions. In addition to offering a variety of specialized, innovative and essential research services, techniques,
and instrumentation, the core will provide hands-on training to students, postdocs, fellows and young scientists
as well as consultation services and access to state-of-the-art research equipment. Moreover, the core will
provide support for preparation of manuscripts and grant proposals. The scope of the core is well in line with the
overall theme of this PCEN that is “Regulation of cell fate during kidney development and disease”. The
experimental approaches of the PCEN involve examination of epigenetic and transcriptional mechanisms that
control cell fate, plasticity, and identity and the cellular signals underlying the phenotypic transformation that
occurs during kidney injury and repair. The proposed core will provide the specialized technologies and expertise
needed to accomplish the stated goals of the PCEN.